Translational Diagnostics

ABSTRACT: Translational Diagnostics Core
The long-term goal of the Washington University Diabetes Research Center (DRC) Translational Diagnostics
Core is to improve human health by supporting clinical laboratory testing services for research in diabetes
mellitus and related metabolic disorders. Most Core analyses are performed on samples from human studies
and some are performed on samples from animal models. The Core provides expert consultation to
investigators so that the most appropriate tests can be chosen while taking cost and number of samples into
consideration. In addition to quantification of classic metabolic analytes relevant to diabetes, such as insulin
and glucagon, the core also offers assays for diabetes and metabolism relevant molecules, such as
adiponectin and TNFα. For some special analytes, the Core maintains contracts with Quest Diagnostics and
Mayo Medical Laboratories, so that these analyses can be performed at substantially lower cost to DRC
members. Development of new research tests is another important activity of the Translational Diagnostics
Core, which makes available to DRC members analyses with enhanced sensitivity and accuracy that
incorporate the latest advances in diabetes and metabolism research. The Translational Diagnostics Core
provides efficient, high quality diagnostic services promoting the translation of basic scientific discoveries for
the prevention, treatment and cure of diabetes and its complications.
.

Public health relevance
NARRATIVE: Translational Diagnostics Core The Washington University Diabetes Research Center Translational Diagnostics Core performs efficient clinical laboratory testing to support research in the field of diabetes mellitus. The primary goals of the Core are to reduce the high costs of specialty testing and to provide outstanding quality control so that reliable diabetes- related tests are widely available to investigators focused on the pathogenesis, treatment and cure of diabetes and related metabolic disorders.